Yale Clinical Neuroscientist Training Program

Project summary
This proposal describes the Yale Clinical Neuroscientist Training Program (CNSTP), the research education
program for residents in the clinical neurosciences at the Yale School of Medicine. This program integrates the
vast array of innovative and exciting collaborative research opportunities available within the School of
Medicine with a select group of outstanding, dedicated mentors in neuroscience. These mentors were selected
on the basis of significant research accomplishments, a consistent record of independent funding, and an
exceptional track record in the mentoring of clinician-scientists. This group of mentors, when combined with
the vibrant neuroscience community at Yale, a track record of training distinguished clinicians, rich core
facilities and resources, makes the CNSTP at Yale a unique program that develops the careers of physician-
scientists. This program has an established track record of nurturing careers of neurology residents towards
career development awards. This renewal application leverages these existing strengths and strives to
innovate strategies for retention and promotion of outstanding future physician-scientists and seeks continued
NINDS funding to buttress these efforts. Moreover, this renewal application highlights our strategies and efforts
to recruit women and individuals from underrepresented backgrounds in order to strengthen the diversity of our
program, and our ongoing initiatives to teach the ethical and successful scientific practices of science.

Public health relevance
Narrative The Yale Clinical Neuroscientist Training Program (CNSTP) is uniquely designed to provide the research tools, clinical skills, and mentorship required for the transition from resident to independent faculty member. Our program seamlessly integrates research and clinical training using the vast educational and research resources at Yale and fosters trainees to become creative and innovative scientists that are equipped to successfully obtain a mentored career development award, and ultimately lead an independently funded research laboratory. Diversity, ethics and responsible conduct is of great importance to our program and so we are committed to the recruitment of women and individuals from underrepresented backgrounds in order to strengthen the diversity of our program, and to a newly created Plan for Ethical and Successful Scientific Practice that will build on our current Responsible Conduct of Research plan, all part of a program of excellence designed to develop the next generation of leaders in academic medicine.